TET-mediated epigenetic regulation in cardiac development.

Project Summary/Abstract
Epigenetic regulatory pathways governing gene expression are intimately involved in the regulation of early
heart development and cardiac remodeling under pathological stress. Disrupting the cardiac transcriptional
networks during early heart development and cardiac regeneration may lead to heart diseases. Among all the
known epigenomic modifiers, the Ten-Eleven Translocation (TET) protein family is a relatively new member
found to mediate the reversal of DNA methylation in the mammalian genome. The TET dioxygenases (TET1-3)
are capable of converting 5-methylcytosine (5mC) to 5-hydroxymethyl-cytosine (5hmC) and further oxidized
species, thereby promoting active DNA demethylation. The dynamic changes in 5mC/ 5hmC distributions and
transcriptional reprogramming play vital roles during early CM development, a critical period that also provides
an optimal time window to study fundamental epigenetic regulatory mechanisms that govern cardiac gene
transcription. Our own preliminary studies revealed that genetic depletion of Tet proteins in mice impaired early
cardiomyocyte (CM) development. At the cellular level, Tet-deficient CMs further exhibited reduced
proliferation and metabolic dysfunction. At the molecular level, upon Tet deletion, we observed massive
changes in DNA methylation and a disorganized chromatin architecture that might account for disrupted
cardiac transcriptional networks and abnormal expression of key metabolic genes involved in proliferation,
glycolysis and mitochondrial respiration in CMs. We hypothesize that the Tet-mediated DNA demethylation
pathway is critical for maintaining proper chromatin accessibility and chromatin looping, thereby regulating
transcriptional programming to instruct CM development. The immediate availability of a cardiac-specific Tet
triple knockout mouse model, as well as a set of innovative tools developed for precise mapping and editing of
DNA modifications, has placed us in an extremely competitive position to unravel novel epigenetic regulatory
mechanisms controlling CM development. In Aim 1, we will define how Tet/5hmC regulate chromatin
accessibility and the binding of key transcriptional factors to their targets to program essential transcriptional
outputs and maintain proper CM development. In Aim 2, we will examine how Tet/5hmC regulate chromatin
looping by interplaying with enhancer and insulator elements at critical genomic loci to control metabolic gene
expression during CM development. Upon completion of our proposed studies, we anticipate to establish a
new paradigm by introducing a previously underappreciated dimension in the epigenetic regulation of the
cardiovascular system. Findings from our proposed studies will also provide novel insights into the molecular
mechanisms responsible for cardiac gene transcription and heart development, thereby forming a solid basis
for developing potential epigenetic therapies to prevent and treat congenital heart diseases.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE STATEMENT This project is tightly connected to the NIH mission by unveiling new molecular mechanisms that account for abnormal heart development, with a focus on the TET-mediated DNA modification pathway. Knowledge gained through our proposed studies will significantly advance our understanding of the developmental process of the heart, as well as the origin of congenital hearts diseases. Our discoveries will potentially lead to novel therapeutics by targeting abnormal DNA modifications for the prevention and treatment of heart defects in infants, thus directly benefiting patients suffering from heart disease.